The Structure and Assembly of the COPII Coat

DESCRIPTION (provided by applicant): COPII proteins play a critical role in the early secretory pathway by transporting protein and lipid cargo out of the endoplasmic reticulum (ER). The COPII proteins consist of Sar1 (a GTPase), Sec23/24 (cargo selection and GAP activity), and Sec13/31 (promotes coat assembly). Together, these form a coat that recruits and concentrates cargo and gradually deforms the ER membrane into a vesicle. Recently, it was found that Sec13/31 self-assembles into a unique cuboctahedron cage-like structure. These structures were solved with cryo-electron microscopy (cryoEM) and single particle reconstruction and yielded insights into some of the mechanisms by which COPII coated vesicles are assembled. These initial studies were bolstered with a new structure of a COPII coat formed from the self-assembly of Sec13/31 with Sec23/24. Together, these two structures form a foundation for dissecting the mechanisms by which the COPII proteins perform their functions in the cell. The current proposal seeks to address questions about COPII structure and assembly through four specific aims. Aim 1 proposes to determine the structures of individual COPII coats and COPII coated vesicles. These structures will shed light on the ways that cargo interacts with Sec23/24 and Sec23/24 interacts with Sec13/31, and thus contribute to a picture of the mechanisms by which cargo directs the assembly of vesicles of the proper size. In aim 2, it is proposed to determine the structure of the COPII coat in complex with Sar1, and these studies will reveal at a molecular level how Sar1 is involved in initiating the formation of the COPII coat. The molecular mechanisms of tethering are explored in aim 3, where it is proposed to determine the structure of the COPII coat in complex with the TRAPPI tether protein Bet3. Finally, aim 4 proposes to develop assays for poisoning COPII cage assembly at various intermediate stages and to determine the structures of the intermediates. Together, these studies will drive the vesicle transport field by furthering our understanding of COPII structures and how they are assembled in the cell. This, in turn, will aid in the understanding of the role COPII proteins play in diseases like chylomicron retention disease and cranio-lenticulo-sutural dysplasia, which result from mutations in Sar1 and Sec23/24 respectively, and diseases that manifest as transport defects such as cystic fibrosis.

Public health relevance
PUBLIC HEALTH RELEVANCE: The COPII proteins are involved in the secretory pathway, which is a critical and fundamental pathway in eukaryotes such as humans. Two diseases, chylomicron retention disease and cranio-lenticulo sutural dysplasia, are associated with mutations in COPII proteins, and a host of diseases including cystic fibrosis result from mutations that cause the proteins to be retained in the ER. Understanding of the mechanisms by which cargo proteins interact with the COPII coat and how COPII coat assembles will help us understand the role COPII plays in these diseases and may help in identifying novel targets for therapeutics. Project Narrative The COPII proteins are involved in the secretory pathway, which is a critical and fundamental pathway in eukaryotes such as humans. Two diseases, chylomicron retention disease and cranio-lenticulo sutural dysplasia, are associated with mutations in COPII proteins, and a host of diseases including cystic fibrosis result from mutations that cause the proteins to be retained in the ER. Understanding of the mechanisms by which cargo proteins interact with the COPII coat and how COPII coat assembles will help us understand the role COPII plays in these diseases and may help in identifying novel targets for theraputics. __SpecificAimsTextDelimiter__ Specific Aims COPII coated vesicles mediate the transport of biological cargo from the endoplasmic reticulum (ER) to the Golgi apparatus. Nearly 1/3 of the proteins encoded by the eukaryotic genome are transported through this pathway, highlighting the critical role COPII proteins play in the cell. Moreover, diseases such as chylomicron retention disease and cranio-lenticulo-sutural dysplasia are associated with mutations in COPII proteins, and mutations in cargo proteins can result in the cargo proteins failing to engage the COPII machinery, as is the case in cystic fibrosis and other diseases. Thus, the COPII pathway is relevant for both basic and medical research. COPII vesicles are assembled from the association of three subunits: Sar1, Sec23/24, and Sec13/31. Each of these proteins plays a specific role in the generation of a vesicle. Sar1 is a regulatory GTPase. In its activated conformation, Sar1 binds ER membranes and recruits Sec23/24, which in turn recruits cargo proteins. Sec13/31 forms an outer cage structure that is thought to cluster Sec23/24-cargo complexes on the ER membrane. Multiple Sar1-Sec23/24-Sec13/31 complexes are then thought to interact to form a lattice that deforms the ER membrane into a sphere, culminating in vesicle fission. Once the vesicle is formed and on its way to the Golgi apparatus, the COPII coat becomes unstable and dissociates. Previously, we found that Sec13/31 can self-assemble, and using cryoEM and single particle reconstruction techniques, we determined the structure of these complexes. This revealed that Sec13/31 forms a novel cuboctahedron cage (here called the COPII cage), and allowed us to determine some of the rules that dictate the formation of COPII coated vesicles. We extended these results by assembling Sec13/31 together with Sec23/24 and solving the structure of the corresponding complexes (here called the COPII coat). The structure of the COPII coat revealed that Sec13/31 forms an outer cage layer while Sec23/24 forms an inner adaptor layer that is well positioned to interact with cargo. Together, the structures of the COPII coat and COPII cage yielded insights into some of the mechanisms by which COPII proteins function in the cell and opened the door to asking questions about the mechanisms by which the COPII coat interacts with cargo, assembles, and forms vesicles of the appropriate size for the cargo. We propose to address these questions through the following specific aims: Aim 1) Characterize and determine the ensemble of structures of COPII coats and coated vesicles. We will use cryo-electron tomography (cryoET) to determine the structures of individual COPII coats and coated vesicles. We will determine the structures of COPII coats assembled from purified Sec13/31 and Sec23/24 and COPII coated vesicles budded from ER derived microsomes. These studies will yield a wealth of information about COPII structure and assembly. By determining the structures of individual COPII coats using cryoET (as opposed to averaging tens of thousands as we would with single particle reconstructions), we will gain insights into the interaction between Sec23/24 and Sec13/31 and the range of geometries that Sec13/31 can accommodate. CryoET of COPII coated vesicles will reveal how the Sec23/24 adaptors interact with cargo proteins, and how together these may help dictate the size of the COPII vesicle. Finally, the EM studies will be complemented by analytical ultracentrifugation that will yield information about the number, size, and relative proportions of different COPII complexes. Aim 2) Visualize how Sar1 influences the assembly and disassembly of the COPII coat. We will determine the 3D structure of the COPII coat in complex with Sar1. This aim will be accomplished by assembling the COPII complexes in vitro from purified components and solving their structures using cryoEM and single particle reconstruction. Sar1 is known to regulate the assembly of the COPII coat, but it is controversial whether it is involved in the disassembly as well. By determining the 3D structure of the full complex of Sec13/31, Sec23/24 and Sar1, we will gain insight into the way the conformational state of Sar1 is involved in controlling the assembly and disassembly of the entire complex. Aim 3) Characterize the role of the COPII coat in tethering. We will determine the structure of the COPII coat in complex with the tether protein Bet3. This aim will be accomplished by assembling the COPII complexes in vitro from purified components and solving their structures using cryoEM and single particle reconstruction. Tether complexes are involved in providing specificity for fusion of vesicles with their cognate downstream compartments. Recent evidence has shown that Bet3 interacts with Sec23/24, and this confers the specificity of COPII tethering. Furthermore, Sec13/31 was shown to colocalize with Bet3 in vivo, but given that Sec23/24 is largely obscured by Sec13/31 in the COPII coat, it is unclear if tethering can occur when the full COPII coat is intact. By solving the structures of Bet3 bound to Sec23/24 alone and in the full COPII coat, we will identify the binding site for Bet3 on Sec23, and this will give us insights into the molecular mechanisms of tethering and whether tethering can occur with the COPII coat intact. Aim 4) Characterize the ensemble of COPII assembly intermediates. The self-assembly of the COPII cage appears to be mediated by three to four unique contacts between adjacent Sec31s at the cage vertices. We will specifically identify these contacts by hydrogen/deuterium exchange Fourier transform ion cyclotron resonance mass spectroscopy. Using this information, we will design a faulty Sec13/31 heterotetramer that we will add to wild type Sec13/31 in a COPII cage assembly reaction. The faulty Sec13/31 should act to stop the formation of COPII cages at random stages of assembly (this is similar in concept to dideoxyDNA nucleotides in a Sanger sequencing reaction). Thus, at the end of the assembly reaction, we should have recapitulated the entire assembly pathway for COPII cages. We propose to use kinetics, cryotomography, and analytical ultracentrifugation and size exclusion chromatography coupled to multi-angle light scattering to determine the structures and relative proportions of the COPII assembly intermediates, and this will give us insights into the mechanisms by which the COPII coat assembles and disassembles in the cell.